CYTOSOLIC CALCIUM, INSULIN RESISTANCE, AND NONMODULATION

This study is assessing the linkage between non-modulation and insulin resistance. Varying degrees of insulin resistance are induced by changes in weight. Changes in angiotensin II levels are induced by sodium restriction and loading. Insulin resistance and adrenal and vascular responses to angiotensin II are assessed along w/ cytosolic calcium levels in lymphocytes.